Molecular Basis of SIX2-related Frontonasal Dysplasia

Frontonasal dysplasia (FND) are congenital craniofacial disorders characterized by ocular hypertelorism,
anterior cranium bifidum, and median facial clefting affecting the nose and upper lip/palate. These birth
defects profoundly disrupt the integrity and function of the skull and orofacial complex, often causing life-long
impairment. The causes and pathogenic mechanisms underlying FND are mostly unknown, which
significantly hinders improvement in FND diagnosis and clinical management. Recently, three independent
studies have identified heterozygous microdeletions at Chromosome 2p21, in which SIX2 is the only protein-
coding gene, in association with an autosomal dominant FND syndrome and suggested SIX2
haploinsufficiency as a cause. However, other patients heterozygous for smaller genomic deletions also
containing all SIX2 coding sequences did not exhibit FND. SIX2 is a member of the sine oculis homeobox
(SIX) family DNA-binding transcription factors. In all vertebrate genomes, Six2 is physically linked to Six3 in
a tail-to-tail configuration, with these two paralogous genes organized into separate topologically associated
domains (TADs) flanking a TAD boundary. Whereas Six2, but not Six3, is abundantly expressed in the cranial
neural crest cell (CNCC) derived frontonasal mesenchyme and in nephrogenic mesenchyme during mouse
embryogenesis, Six2-/- mice exhibited kidney hypoplasia but normal frontonasal structures. Our preliminary
studies found that CRISPR/Cas9-mediated deletion of a 99-kb region containing the Six2 gene and the
predicted TAD boundary, but not including the Six3 gene, caused severe FND with median facial cleft in
heterozygous mice, but extending the deletion to 110-kb to include both the Six3 and Six2 genes resulted in
phenotypically distinctive and viable heterozygous mice. Analysis of ENCODE chromatin conformation
capture data from multiple human cell lines suggests that the FND-associated 2p21 deletions likely disrupted
the TAD boundary between SIX2 and SIX3. This R21 project will test a novel hypothesis that the pathogenic
mechanism of SIX2-related FND involves ectopic expression of the neighboring SIX3 gene resulting from
TAD fusion and enhancer-promoter rewiring, not simply SIX2 haploinsufficiency, through generation and
analyses of new genome-edited mouse model as well as isogenic pluripotent stem cell lines carrying distinct
FND or non-FND associated SIX2 genomic deletions. Data from these studies are expected to provide new
insights into pathogenic mechanisms of currently uncharacterized craniofacial and other disorders associated
with structural variations that alter the chromatin landscape, and lead to new improvements in molecular
diagnosis and treatment/care of such patients.

Public health relevance
Narrative Frontonasal dysplasia (FND) are congenital craniofacial disorders that profoundly impact the form and function of the face, nose, and mouth. FND patients require multiple corrective surgeries and often suffer life-long impairment. Using novel mouse and human pluripotent stem cell models, this project will uncover the underlying molecular genetic basis and lead to significant improvement in molecular diagnosis, genetic counseling, and treatment of patients with FND and related craniofacial disorders.